Survey Research Shared Resource

SURVEY RESEARCH SHARED RESOURCE PROJECT SUMMARY
The purpose of the Survey Research Shared Resource (SUR) is to facilitate the conduct of high quality science
through the provision of experienced consultation and service delivery for all aspects of survey design and
conduct for Mayo Clinic Cancer Center (MCCC) memberss. Under the leadership of Kathleen Yost, PhD since
2016, the SUR strives for excellence by providing high quality and efficient service delivery by deploying “state
of the science” methods in the areas of instrument development (including cross-cultural adaptation), sampling,
methods of survey administration (paper, telephone, and computer, including mobile devices), response
tracking, instrument processing, complex survey weighting, and response data file preparation. The SUR is the
only Mayo Clinic resource offering this comprehensive set of services.